Structure and mechanism of the kidney disease-causing protein APOL1

PROJECT SUMMARY
In the United States, people of recent African ancestry are four times more likely to develop chronic kidney
disease (CKD) and end stage kidney disease (ESKD) than non-Hispanic whites. While some of this risk can be
attributed to differential access to care and social determinants of health, much of this excess risk can be
attributed to two “high-risk” variants in the Apolipoprotein L1 (APOL1) gene. Patients with APOL1-associated
kidney disease are diagnosed with CKD at younger ages, have more rapid CKD progression, and are less
likely to respond to existing therapies. Although the link between the high-risk APOL1 genotype and the
increased risk of kidney disease is well-established, basic questions about the structure of the APOL1 protein
and the differences in activity between the high- and low-risk variants remain unanswered. Purified bacterially-
expressed APOL1 proteins have been observed to have nonselective cation channel activity. However, the
oligomerization state of the active APOL1 channel and the structural determinants of its selectivity are
unknown. Furthermore, the functional effects of the high-risk variants on APOL1 channel activity are unknown.
In preliminary work, I have purified eukaryotically-expressed, recombinant APOL1 proteins and shown that
they can form active ion channels in vitro. I hypothesize that APOL1 forms oligomeric nonselective cation
channels, and that channels composed of high-risk variant APOL1 proteins permit greater cation currents than
channels composed of the low-risk variant protein. To test this hypothesis, I propose two specific aims. In Aim
1, I will solve the structure of the APOL1 protein using electron microscopy. In Aim 2, I will reconstitute purified
APOL1 proteins into liposomes and characterize their activity using fluorometric liposome efflux assays. In
pursuing this work, I will gain critical skills and expertise necessary to study the structural and biophysical
properties of membrane proteins involved in the pathogenesis of kidney diseases. I will develop as a physician-
scientist through formal coursework, scientific programming, and direct mentorship from experts in kidney
disease, structural biology, and ion channel physiology. The proposed research aims and career development
plan will help me establish a career as an independent investigator who studies the fundamental biochemical
and biophysical processes that cause kidney disease, while continuing to treat patients with kidney disease as
a nephrologist.

Public health relevance
PROJECT NARRATIVE Variants in the Apolipoprotein 1 (APOL1) gene are major contributors to the increased burden of kidney disease in people of recent African ancestry; despite significant previous work investigating the pathogenesis of APOL1-associated kidney disease, basic questions regarding the APOL1 protein itself remain unanswered. In preliminary work, I have purified eukaryotically-expressed, recombinant APOL1 proteins and shown that they function as ion channels. I propose to determine the structure of the APOL1 protein and to determine how the high-risk variants functionally differ from the low-risk variant in vitro; these studies will improve our understanding of the mechanisms that cause APOL1-associated kidney disease and will help us develop new assays to identify drugs that specifically target APOL1.